Glovebox Workstation for Shared-Use Biomedical Research Facilities

Project Summary/Abstract.
At Hawaii Pacific University (HPU) multiple Principal Investigators in the College of Natural and
Computational Sciences have focused their research agenda on research questions pertaining to
biomedical research and in training undergraduate student researchers in this context. Biomedical
research in the College has benefitted from NIH funding, especially through the Hawaii
Institutional Development Award Network for Biomedical Research Excellence (INBRE). Ongoing
work in the College includes isolation, structural characterization, and bioactivity screening of
natural products; maintaining libraries of terrestrial and marine plants, invertebrates, and
microorganism samples unique to Hawaii; analyzing plastic additives on marine organisms; and
conducting fundamental studies on the reactivity of titanium and zirconium—oxygen multiple
bonds, which are present in sunscreens, dental restorations and crowns, and biomedical implants.
This academic year HPU opened a new 20,000 sq. ft. shared-use teaching and research
laboratory in downtown Honolulu. The lab houses communal instruments including an NMR,
GCMS, LCMS, and IR spectrometers, UV-vis and fluorescence spectrophotometers, PCR,
polarimeter, and patch-clamp electrophysiology setup. Our College’s research in this new shared
lab space would greatly benefit from access to a rigorously air- and moisture-free atmosphere for
synthesis and/or storage of dry, air-sensitive, and pyrophoric reagents; storage and manipulation
of HPU’s natural product extract library; sample preparation for NMR and fluorescence
spectroscopy; and for collecting electrochemical measurements. To support these activities, we
request a glovebox workstation and nitrogen gas generator. The nitrogen gas generator will be
able to purify the house compressed air to 99.9995% nitrogen gas, supplying the glovebox with a
dry and inert atmosphere. The glovebox workstation will be equipped with a freezer, cold-well,
and electrical posts to meet the diverse research needs of each Principal Investigator’s team of
student researchers.

Public health relevance
Project Narrative. The Hawaii Institutional Development Award Network for Biomedical Research Excellence (INBRE), funded by the National Institute of General Medical Sciences (NIGMS) has helped to shape the research landscape at HPU. This network has facilitated collaboration across the state in training a pipeline of qualified students interested in biomedical careers and advancing research progress in natural products discovery and molecular medicine influenced by the unique and diverse marine and plant life in Hawaii. Research projects within this network would benefit from access to the rigorously oxygen- and moisture-free environment provided by a glovebox workstation supplied by a nitrogen generator.